MUTAGENESIS IN MAMMALIAN CELLS

I propose to analyze the molecular basis of spontaneous mutagenesis in mammalian cells infected with herpes simplex virus type 1. I have chosen this system because herpes virus codes for many DNA metabolic functions (including a DNA polymerase), making it readily susceptible to biochemical and genetic analysis. Also, mutations in the viral thymidine kinase gene are readily detected and characterized. I will test whether the viral DNA polymerase influences the production of point mutations. The approach is to determine whether viral strains carrying altered DNA polymerases exhibit altered production of point mutations in the viral thymidine kinase gene. DNA polymerase from mutator and/or antimutator strains identified on this basis will be purified and compared biochemically to the wildtype polymerase. Specific comparisons will be made of (1) the abilities of these enzymes to select correct base pairs during polymerizarion and (2) the levels and specificities of the polymerase-associated 3 feet to 5 feet exonucleases. Mutations due to genetic rearrangements are also known to be quite common in mammalian cells. Further objectives of this study are to deternine (1) wheteher this class of mutations occurs in the herpes thymidine kinase gene, (2) if so, what types of rearrangements are observed and (3) whether tranposable elements play a role in mutant production.